Neighborhood Social Environment, Composition and Depression in Latinx

Project Summary/Abstract: Depression is one of the most prevalent mental health disorders in the United
States. Further, Latinos in the US represent one of the fastest growing ethnic groups and report the second
highest rates of depression, making their growing presence in neighborhoods and their well-being relevant to
the overall success of the nation. Yet the effects of neighborhood-level factors on depression, particularly in
Latinos, remains understudied. There exists a paucity of research that examines the effect of residential
segregation on mental health. Fewer still has assessed causal pathways— including through neighborhood
features such as neighborhood social cohesion (NSC) and neighborhood problems (NP)—using rigorous
quantitative methodologies. Additionally, NSC is of particular interest due to the potential mental health
benefits it may have. However, the literature examining for what subgroup of Latinos NSC is most helpful for
depression and what the spatial relationship may be is limited. In an effort to address these gaps, I will
examine 1) The direct and indirect effect of residential segregation on depressive symptoms at two time points
in Latinos through individual-level NSC and NP, 2) The cross-sectional direct and indirect effect of residential
segregation on depressive symptoms in Latinos through neighborhood-level NSC and NP, 3) Effect
modification of the association between individual level NSC on depressive symptoms by language proficiency
while accounting for neighborhood differences, and Exploratory) To explore the spatial relationship between
individual-level NSC and depressive symptoms in Latinos. Method & Analysis: This dissertation study will
employ multilevel models in order to account for clustering in two population-based datasets: the Latino sample
in the Multi-Ethnic Study of Atherosclerosis and its ancillary Neighborhood Study (Aim 1,2) and the Hispanic
Community Health Survey/Study of Latinos and its Sociocultural Ancillary Study (Aim 3). In order to address
gaps in the literature I will 1) carryout a mediation analysis using a multilevel model across two time points
(2003, 2010) to examine the direct and indirect effects of residential segregation on depressive symptoms
through individual-level NSC and NP (AIM 1). To address same source bias in using individual-level NSC and
NP as mediators, a cross-sectional (2010) multilevel model will be used to examine the direct and indirect
effects of residential segregation on depressive symptoms using neighborhood-level measures of NSC and NP
(AIM 2). Multilevel models will also be employed to examine effect modification of the association between
NSC and depressive symptoms by language proficiency (AIM 3). Contributions: The 2-year training program
and dissertation proposed in this F-31 fellowship application will support me in developing skills and methods
in neighborhood effects research critical to the completion of my dissertation study and doctoral research
training. The fellowship will ultimately further my goal of becoming an independent research scientist that will
address mental health inequities through neighborhood effects research in minoritized populations.

Public health relevance
PROJECT NARRATIVE Depression in the United States is one of the most common psychiatric disorders and can represent a significant cost to quality of life. Findings from the proposed research would enhance knowledge on the effects of neighborhood-level features such as residential segregation and neighborhood social cohesion on depression and the pathways leading to the association in Latino communities. This research would lay the foundation for the development of strengths-based interventions that may be leveraged to improve the mental health of Latinos and other underserved communities and in turn advance mental health equity.